Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative (Admin) Core provides leadership, management, and oversight for the Center as a whole
and high quality, efficient, and cost-effective administrative and financial services that increase the productivity,
quality, and innovation of CCPR Fellows' research. The leadership, management, and oversight provided by
the Directors are essential to the day-to-day operation of the Center, to understanding changing needs of
Fellows, to adapting to the changing administrative requirements within UCLA and at funding agencies, and to
advocating for the Center within competitive University and extramural funding environments. The Admin Core
sets priorities for the Center; fosters a highly interactive, supportive, and stimulating intellectual environment
within the Center; allocates resources (e.g., office space, staff time, equipment use); assists researchers in the
preparation of grant proposals and cost-effective use of grant funding; ensure that Fellows needs are being
met; ensures continuing strong University support for CCPR; and advocates on behalf of CCPR Fellows within
and outside of UCLA. The Admin Core also serves the Development Core and Scientific and Technical Core.
The Admin Core has four specific aims: 1) Provide high quality, responsive administrative services that
enhance CCPR Fellows' research and advance the careers of junior faculty; 2) Promote a productive,
collaborative, and stimulating interdisciplinary CCPR research community; 3) Evaluate CCPR to maintain and
support high quality and responsive activities and services to meet Fellows' research needs; 4) Communicate
CCPR's interests and research within and outside of UCLA. The activities and services and new initiatives in
the Admin Core foster CCPR's highly successful, innovative, cutting-edge research by CCPR Fellows and
support the development of highly talented and productive junior population scientists. It evaluates CCPR
activities and services and makes modifications where needed. The Core also enhances access to population
scientists at under-resourced institutions.